Wisconsin National Primate Research Center Support

Summary/Abstract. The Wisconsin National Primate Research Center (WNPRC) is one of seven federally supported National Primate Research Centers and the only one in the Midwest. WNPRC's mission is to increase the understanding of basic primate biology and to improve human health and quality of life through research. To accomplish this, the WNPRC helps discover treatments, preventions and cures for human disease;? generates new knowledge of primate biology, from the molecular and whole animal levels to the understanding of primate ecosystems;? facilitates research progress by providing expertise, resources and training to scientists worldwide;? and collects primate information and disseminates to the research community and to the public.

Public health relevance
RELEVANCE. The Wisconsin National Primate Research Center (WNPRC) base operating grant supports services and resources for research addressing human health issues utilizing non-human primate (NHP) models. The WNPRC provides a rich and integrated portfolio of cutting-edge services, resources, and scientific expertise that support NHP research with high impact and direct relevance to human and animal health and disease. With ongoing additions to WNPRC infrastructure, and expansion of the Center's scientific components and collaborations, the WNPRC is poised to advance the translation of NHP research findings into new remedies for some of our society's most pressing medical problems.